Menopausal Knee-ds: Elucidating mechanisms and treatments for knee osteoarthritis

PROJECT SUMMARY/ABSTRACT
Background: As of 2020, an estimated 654.1 million adults live with knee osteoarthritis (KOA), and women who
are post-menopausal are nearly twice as likely to develop KOA compared to men. Despite this, most animal
studies on KOA include only males, and, of the few studies utilizing females, menopause is typically not included,
as it is not a naturally occurring process in non-primates. As such, there is a paucity of literature aimed at
understanding mechanisms of menopause associated KOA and a corresponding absence of treatment
interventions specifically for post-menopausal people with KOA. As a part of my PhD work thus far, I have
developed a chemically-induced menopause model by injecting middle-aged female mice with 4-
vinylcyclohexene diepoxide (VCD). I have confirmed this model displays a menopausal phenotype, including
perimenopause, and that these mice display more severe KOA than age-matched, non-menopausal mice.
The research goals of this fellowship are to interrogate mechanisms of menopause-induced KOA using
our VCD model (Specific Aim 1) and employ synthetic biology techniques to lay the groundwork for new
treatment modalities for menopause-indued KOA and (Specific Aim 2).
Specific Aim 1: A component of E3 ubiquitin ligase was recently identified in a GWAS meta-analysis as a unique
contributor to OA in women. As such, I will interrogate the role of estradiol-regulated, ubiquitin proteolysis in
mediating menopause-induced KOA using our VCD menopause model. Changes in ubiquitin proteolysis
signaling across perimenopause, menopause, and with estradiol treatment will be quantified both in vivo and in
vitro. We hypothesize that (1) menopause induction will disrupt ubiquitin proteolysis activity and (2)
estradiol treatment started early in menopause will restore ubiquitin proteolysis signaling and ultimately
quinch menopausal KOA.
Specific Aim 2: I will design an estradiol-regulated controls circuit to modulate a gene of interest (GOI) in vitro.
A significant drop in estradiol is a principal physiological change associated with menopause, and an estradiol-
repressed promoter will be designed to turn the circuit on. GOI candidates will be generated from previous
studies and will be systematically tested to determine ideality for mediating chondrogenicity. We hypothesize
that a genetic controls circuit modulated by estradiol will attenuate chondrocyte health in vitro.
Impact: To support my fellowship, I have assembled a multidisciplinary team with expertise in KOA, menopause,
aging, and synthetic biology. I have strategized with my mentoring team to design a rigorous training plan that
will take advantage of the extraordinary research environments offered at my sponsor’s new institution
(Spaulding Rehabilitation, Harvard Medical School) and the University of Pittsburgh, where I remain a full-time
student. This fellowship will propel me towards my long-term goals of being a physician-scientist who practices
orthopedic surgery and research leader in joint diseases and injuries presenting in women.

Public health relevance
PROJECT NARRATIVE Post-menopausal women are twice as likely to develop knee osteoarthritis than men; yet there are currently no animal studies aimed at understanding how natural menopause propagates knee osteoarthritis and, thus, no specific treatments for post-menopausal people with knee osteoarthritis. This proposal interrogates the role of pathologic protein turnover in menopause-induced knee osteoarthritis and employs synthetic biology techniques to develop an estradiol-regulated genetic controls circuit. Completion of these studies will provide insight into the underlying mechanisms of menopause-induced knee osteoarthritis and provide the first steppingstone for gene- therapy treatments for this disease.